Glutamate Chemical Exchange Saturation Transfer (GluCEST) Imaging in Cognitive Aging

Healthy older adults (HOA) confront complex and life-changing decisions in the face of declining neural resources. Changes in aged brains include shrinkage of neurons and their projections in several areas, such as the neocortex, hippocampus and substantia nigra.1 These age-related structural brain changes, typically measured using in vivo techniques (e.g. MRI), reflect cellular changes. Glutamate (Glu) is a key molecule in cellular metabolism, the most abundant excitatory neurotransmitter in the mammalian nervous system, and the principal neurotransmitter of cortical efferents.2,3 Alterations in brain Glu likely contribute to the neural mechanisms underlying age-related declines in behavioral and cognitive functions.4 Yet, only a few studies4-11 have investigated age-related changes in brain Glu, in vivo, during healthy aging. Most of these have used standard techniques and as a result our understanding of the role that brain Glu has in typical and atypical aging remains limited. Here, I aim to fill significant gaps in the field, by 1) assessing brain Glu using a novel magnetization transfer technique?Glutamate Chemical Exchange Saturation Transfer (GluCEST)?on an ultra-high field 7T MRI scanner, enables the measurement of brain Glu across the cerebrum in humans.12; 2) assess cognitive performance using a highly sensitive computerized neurocognitive battery (Penn Computerized Neurocognitive Battery (CNB)); and 3) explore the possibility of aging biotypes based upon age- related changes in brain glutamate. Here, we propose to investigate alterations in brain glutamate in 100 HOA (60-85 years of age) using GluCEST 7T MRI and relate alterations in brain Glu to age-related changes in cognitive functioning, including, memory, and executive function. Moreover, we will contrast age-related patterns with data from young adults (18-30 years of age). Finally, we leverage data from a large consortium, iSTAGING (directed by Co- Investigator Davatzikos), to employ recently developed machine-learning techniques (e.g. HYDRA13), to classify subgroups of older adults based upon unique patterns of brain structure associated with typical, atypical and resilient aging. These subtypes will be applied within our sample and patterns of brain glutamate can then be measured within these subtypes. The proposed studies will provide more specific and sensitive in vivo measurements of brain glutamate in HOA. This proposal will enable testing of specific hypothesis about the regional distribution of brain Glu, its relation to aging, and its contribution to cognitive functioning in aging. As such, these studies can provide crucial preliminary data for longitudinal studies in healthy and pathological aging by targeting a specific neural mechanism associated with cognition and disease progression.

Public health relevance
RELEVANCE Older adults tend to focus on positive emotional information more than their younger counterparts. The psychological and neural mechanisms of this positivity bias remain unclear and it is possible that an age-related reduction in executive function contribute to this bias. Moreover, it remains unclear whether the positivity bias is maintained in those at risk for developing dementia. This positivity and and roject aims to characterize this emergence of this bias across the lifespan and determine its role in the early stages of dementia those at risk for developing dementia using computerized assessment of emotion cognition. p